Administrative Core

This P50 application represents a novel interdisciplinary center at the intersection of behavioral economics and
implementation science in pursuit of improving cancer care delivery. The Administrative Core for the University
of Pennsylvania Implementation Science Center in Cancer Control (Penn ISC3) will provide overarching
operational and scientific oversight. It will be led by the three Penn ISC3 Principal Investigators, Drs. Beidas,
Bekelman, and Schnoll, in collaboration with an Internal Executive Committee and an External Advisory Board.
The Specific Aims of the Administrative Core are as follows: 1) To provide essential management and integration
of Penn ISC3 activities (operational structure),which will include administrative support, meeting coordination,
and ensuring the effective use of the Internal Executive Committee and an External Advisory Board; (2) To serve
as the hub for implementation science (IS) research in cancer at Penn (IS outreach), which will involve
coordination of educational activities, drawing upon essential partnerships at Penn, engage in activities to ensure
communication, engaging with other centers funded through this mechanism, and coordinating an annual retreat;
(3) To coordinate communication and dissemination of the Center’s research findings, build research capacity
and collaboration with other Moonshot awardees, and support a national implementation science and cancer
research community (network unit); and (4) To support, monitor, and evaluate Center progress (evaluation unit),
which will ensure completion of proposed studies, determine the broader impact of the Center, and help to
translate the results of the proposed studies into subsequent funded research projects. The overarching priority
for the Administrative Core is to ensure that the impact of the Penn ISC3 is robust and greater than the sum of
its parts. It will do so by coordinating services and maximizing synergies among the Research Program,
Implementation Laboratory, and other center activities. The Administrative Core will interface with the Research
Program (Project PIs and Methods Unit) regularly to ensure that each entity is meeting goals and objectives, and
problem solve as necessary. The proposed Penn ISC3 will bring together junior and senior investigators from
multiple disciplines, which will create a fertile environment with the long-term goal of improving cancer care
delivery and exerting a sustained impact on public health in partnership with key stakeholders. Ultimately, the
Penn ISC3 Administrative Core will create a culture of exceptional science and ensure the Center’s success by
stimulating and guiding new conceptual and methodological advancements, supporting the growth of IS and
cancer research at Penn and nationally, and advancing the science of implementation within oncology care.
PHS 398/2590 (Rev. 06/09) Page Continuation Format Page